The scope, cause and consequences of age-related decline in neural distinctiveness and brain signal variability in healthy and pathological aging

Project Summary
Normal aging is typically associated with pervasive declines in cognitive, motor and sensory function, however,
there are substantial individual differences: some older adults experience mild impairments while others
experience severe cognitive declines. Understanding the neural bases of individual differences during aging is
imperative in designing future interventions to address age-related cognitive impairments. Using behavioural
testing, functional MRI, spectroscopy and pharmacological manipulations in human adults, I propose to
investigate the scope, cause and consequences of age-related decline in two neural factors that may play a
role in these individual differences: (1) neural distinctiveness (how similar/confusable neural activation patterns
are in response to different stimulus categories) and (2) brain signal variability (moment-to-moment change in
neural activity independent of task). Both these measures have been found to decline with age and both have
been associated with individual differences in behavior. During the predoctoral (F99) phase of the training, my
research will focus on healthy aging: 1) investigating the scope and cause (specifically role of GABA levels) of
age-related decline in neural distinctiveness in sensory regions, 2) the cause of age-related declines in brain
signal variability, and 3) the behavioral consequences of age-related declines in these two neural measures.
During the postdoctoral (K00) phase, I will extend my previous research to again study neural distinctiveness
and brain signal variability, but now in the context of memory and hippocampal dysfunction, and in a clinical
population (patients with Mild Cognitive Impairment, MCI). I will use task-based fMRI to measure neural
distinctiveness, resting-state fMRI to measure brain signal variability, and MR spectroscopy to measure levels
of various neurotransmitters (including glutamine, glutamate, NAA, and GABA), all in the hippocampus, in
healthy younger and older adults as well as MCI patients. I will also collect behavioral data from the same
participants during the Mnemonic similarity task (MST), a highly sensitive measure of hippocampal dysfunction.
I propose to investigate a) age-related changes in neural distinctiveness and resting state variability in the
hippocampus, b) the neurochemical basis of these neural changes, and c) the behavioral and pathological
consequences of these neural changes. For all the MCI patients, I will also have access to a rich dataset of
other biomarkers (e.g., longitudinal measures of CSF and PET-based amyloid and tau) collected at UCI’s
Alzheimer’s Disease Research Center (ADRC). I will therefore be able to examine neural distinctiveness and
brain signal variability in the context of the Amyloid Tau Neurodegeneration (biomarker profiling) Framework.
Together, this research could lead to the development of preclinical markers for AD and open new avenues for
early pharmacological interventions to treat cognitive declines in healthy and pathological aging.

Public health relevance
Project Narrative Some people age significantly more gracefully than others, and understanding the neural factors that underlie those individual differences could lead to interventions to slow or even stop age-related behavioral impairments. The objective of this project is to investigate two neural factors that may play a role, namely age-related changes in the distinctiveness of neural representations and age-related changes in the variability of neural signals. This research could lead to the development of better preclinical markers of Alzheimer’s disease and open avenues for pharmaceutical interventions to slow cognitive declines in aging.